Integrating periodontitis assessment in medical research using computationallyenhanced classification

Integrating periodontitis assessment in medical research using computationally enhanced
classification.
Abstract
Periodontitis is one of the most prevalent non-communicable diseases (NCDs) in adults affecting 64.7-million
Americans based on 2009-2012 estimates. Current examination protocols for periodontitis assessment are either
inefficient or inaccurate for population-level studies. Full-mouth examination (FME) is considered the gold
standard for estimating true periodontitis prevalence, however it is among the most resource- and time-intensive
assessment methods in health-research. Despite decades of efforts, oral health researchers have not been able
to pragmatize the development of an accurate partial-mouth examination (PME) protocol. Lack of an
implementable PME is a major barrier for: 1) identifying community health needs globally, 2) determining public
health resource allocation and 3) implementing periodontitis measures in disease association studies; settings
where it is impractical or inefficient to utilize FME. Importantly, emerging evidence has implicated periodontal
inflammation in the pathogenesis of type 2 diabetes supported by robust pre-clinical causation models and
human correlative studies. Nonetheless, definitive data on whether an increased risk for diabetes onset exists in
periodontal patients is lacking because current resource and time demanding full-mouth periodontitis
examinations hinder periodontitis assessment in adequately powered prospective studies. Therefore, despite
the importance of periodontitis-diabetes associations, periodontal measures are often excluded from large
medical cohorts due to funding and logistics limitations. The objective in this application is to enable the
integration of periodontitis assessment in community and population level surveillance by developing and
validating a computationally enhanced PME method for periodontitis assessment with high validity. Conducted
by a strong transdisciplinary team with complementary expertise in epidemiology, global health, biostatistics
and machine learning, and supported by an extensive FME dataset of over 25,000 participants of the continuous
NHANES, the Hispanic Community Health Study (HCHS) and the Oral Infections Glucose Intolerance and Insulin
Resistance Study (ORIGINS), this proposal will pursue two specific aims: 1) to computationally enhance the
prediction of PME utilizing the novel implementation of machine learning in periodontitis classification,
and 2) to assess the performance of the enhanced PME classifier against existing PMEs and “gold
standard” FME in investigating the association between periodontitis and glycemic status. The feasibility of the
proposed approach is supported by strong preliminary data showing that a Support Vector Machines (SVMs)
classifier enhanced the sensitivity of periodontitis prediction from 54% (“naive” counting of diseased sites from a
currently used half-reduced definition PME) to 90% (SVM-enhanced disease classification) while maintaining an
acceptable false positive rate of 3%. Ultimately, this enhanced PME will be utilized for assembling large
populations with periodontitis in a time-cost-effective manner thereby transforming the fields of NCDs
epidemiology and global health surveillance.

Public health relevance
Public Health Relevance The primary goal of the proposed project is to enable the valid assessment of periodontitis in a time-resource efficient manner. The overarching goal of this project is to implement computational methods for periodontitis classification, with a specific application in the integration of periodontitis examination in large medical cohorts to study the relationship between diabetes mellitus and periodontal inflammation. The proposed computationally enhanced periodontitis classification methodology will be broadly applicable to periodontitis surveillance in resource limited settings and will improve dental research and public health by facilitating the integrated assessment of periodontitis in medical research focusing on diabetes, cardiovascular disease and many other inflammatory diseases.